The Impact of Donor Hematopoietic DNMT3A Mutations in Stem Cell Transplant Recipients

PROJECT SUMMARY/ABSTRACT
Hematopoietic cell transplant (HCT) is an important treatment modality for patients with hematologic malignancy
(HM). Its success depends on the ability of donor hematopoietic cells to establish long-term hematopoiesis and
immunologically mediated elimination of residual malignant cells. Clonal hematopoiesis (CH) is an age-related
condition in which detectable somatic mutations alter the biologic function and inflammatory output of
hematopoietic cells, and in non-transplant populations is uniformly associated with adverse outcomes. By
studying 1727 HCT donor-recipient pairs, I found that CH in donors is common and that inactivating mutations
in the gene DNMT3A are the most frequent alterations. My preliminary data shows that donor DNMT3A-CH is
associated with improved global recipient outcomes, mediated by a reduced risk of HM relapse, but also
increases the risk of graft failure in a subset of recipients. Based on these data and the known function of
DNMT3A in hematopoietic cells, I hypothesize that the effects of donor DNMT3A-CH I observe in HCT recipients
are due to engraftment of DNMT3A-mutated long-term hematopoietic stem cells and subsequent altered function
in mature DNMT3A-mutant leukocyte subsets, particularly T cells. To test this hypothesis, I propose the following
two aims: (1) Determine the effect of DNMT3A-CH on normal and impaired hematopoiesis following HCT. I will
use genomic, immunophenotypic, and single-cell technologies to define the characteristics, including cellular
compartment, of donor DNMT3A mutations that engraft in recipients. I will then focus on elucidating the biology
of graft failure developing in recipients of donor DNMT3A-CH. (2) Define the effect of DNMT3A-CH in donor-
engrafted T-cells after transplantation. I will use genomic, immunophenotypic, and single-cell techniques to
determine the effect of donor DNMT3A mutations on T-cell composition and function in recipients after
transplantation, focusing specifically on how DNMT3A mutations modulate the development of T-cell exhaustion.
I will then specifically assess how donor DNMT3A mutations in T cells affect the pathways of immune evasion
utilized by relapsing cases of acute myeloid leukemia. The information gained from these studies will provide
new insights into the biology of post-transplant hematopoiesis and immune surveillance that could have profound
implications for donor selection and strategies to augment the graft-versus-leukemia effect. In concert with the
proposed experiments, I have outlined a five-year career development plan aimed at the goal of becoming an
independent investigator in translational transplant research. I have assembled an advisory committee of globally
recognized experts in hematopoiesis, transplant immunology, and biostatistics, to provide experimental input
and specific training in these fields. Dana-Farber Cancer Institute, which harbors an outstanding research
community and has a long track record for successful mentorship of independent physician scientists, is an ideal
environment for completion of these experiments and realization of my short and long-term career goals.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell transplantation is an important but imperfect modality for the treatment of patients with hematologic malignancies. This project builds on a novel observation that transplant recipients of donors who have acquired mutations in the gene DNMT3A in their hematopoietic cells have improved outcomes after transplant and assesses how donor clonal hematopoietic DNMT3A mutations affect both the bone marrow and T cells of recipients. Understanding these factors will lead to new insights in transplant immunology and new approaches to the care of transplant patients.